Dissecting the Role of Lrh1 in Phthalate-Related Reproductive Impairments: A Cellular and Molecular Approach

Project Summary/Abstract
The World Health Organization reports that approximately 20% of couples worldwide
experience infertility. Phthalates, widely utilized as plasticizers or solvents in a vast array
of consumer products, have been implicated in reproductive disturbances, as evidenced
by human epidemiological studies and rodent research. This proposal is dedicated to
offering comprehensive mentorship and career development in reproductive toxicology
research for pre-doctoral health professionals and graduate students. The project is
centered on the premise that exposure to phthalates at environmentally relevant
concentrations during critical developmental windows for the testis (from embryonic day
15.5 to postnatal day 3) adversely affects spermatogenesis. This is hypothesized to occur
through the disruption of Lrh1 signaling in Sertoli cells, crucial for germ cell development.
Our approach comprises two innovative aims: The first aims to elucidate how phthalates
may impair germ cell development by disrupting Lrh1-mediated regulation of
steroidogenesis and metabolism in mouse Sertoli cells. The second seeks to determine
the effects of phthalates on the functional capacities of both mouse and human Sertoli
cells (using primary cells and cell lines) in vitro by targeting LRH1.
The successful completion of these objectives will significantly advance our
understanding of the molecular dynamics through which phthalates influence gonadal
function and germ cell maturation. Gaining insight into the sex-specific effects of
phthalates will facilitate the development of tailored healthcare interventions for diseases
related to development, reproduction, and endocrine function. This research, alongside
the career development activities proposed, will empower pre-doctoral health
professionals and graduate students pursuing careers in healthcare, setting the stage for
pivotal breakthroughs in medical science. Ultimately, this project aligns with the National
Institute of Environmental Health Sciences (NIEHS) goal to explore the consequences of
environmental exposures on human health, marking a critical step forward in
environmental and reproductive health research.

Public health relevance
Project Narrative Endocrine disruptors like phthalates have been shown to have negative effects on human reproductive health. This proposal aims to further our understanding of how phthalates affect the reproductive systems at a molecular level. These findings could lead to advancements in treating developmental, reproductive, and endocrine diseases. Moreover, this research will offer valuable research experience to pre-doctoral professionals and graduate students pursuing careers focused on improving patient and public health in the healthcare sector.